Optimization of sigma-2 receptor modulators for the treatment of cognitive dysfunction

Abstract ? Project Summary Cognition Therapeutics Inc.’s (Cogrx) mission is to develop effective therapeutics for Alzheimer’s disease (AD). Oligomers of the brain protein Amyloid beta 42 (AβOs) have been identified as toxic components that are involved with disease progression. Cognition has identified a subset of sigma-2 receptor binding modulators that displaces AβOs from synaptic receptor sites and clears them into the cerebral spinal fluid (CSF). These compounds accomplish this by allosterically modulating a key protein regulator of oligomer receptors (the sigma-2/PGRMC1 protein complex), thus destabilizing the oligomer binding site and increasing the off-rate of oligomers, which are then rapidly cleared into the CSF (within hours). As a result, CT1812 restores synapse number and cognitive performance to normal in preclinical AD mouse models (Izzo et al., 2014a, b). CogRx has discovered two CNS drug-like lead series of AβO displacing compounds. Analogs from these series displace oligomers from neurons and completely block AβO-induced membrane trafficking changes and synapse loss in vitro. Members of these series are highly brain-penetrant and completely block oligomer- induced memory deficits in Alzheimer’s disease mouse models. Drug candidate CT1812 from Series 1 is progressing through Phase I clinical trials with an open IND in the US. We have now turned our attention to identifying new candidates to provide a measure of risk mitigation in the event that our current candidate falters due to unforeseen issues. Cognition and Temple University identified a new lead series of sigma-2 receptor binding modulators, originally discovered at Temple University, that block AβO-induced membrane trafficking changes. The feasibility of medicinal chemistry optimization was established in a Phase I STTR project. This Phase II proposal seeks to further optimize this new series by synthesis and testing of new analogs designed to improve pharmacological and ADME properties. This proposal will allow us to expand our portfolio of sigma- 2 receptor binding modulators with the goal of identifying orally efficacious candidates for further development as therapeutics for AD.

Public health relevance
Cognition Therapeutics is a pioneer in the development of high affinity sigma-2 receptor binding modulators that displace AOs from neuronal receptors that mediate synaptotoxicity, clear them into the cerebral spinal fluid, completely eliminate synapse loss and restore normal memory function in transgenic animals. In collaboration with Temple University, Cognition has identified a new series of sigma-2 receptor modulators, initially discovered by Temple researchers, which displace AOs. The requested funding will enable the optimization of this series of small molecules in order to identify suitable bioavailable, potent and selective IND- candidates. These studies will lead to future work to advanced candidates through IND-enabling studies and eventual clinical trials. An optimized AẞO-displacingsigma-2 receptor modulator IND candidate would further expand the portfolio of small molecule drugs available to reverse AD and MCI symptoms and block disease progression.